Limbic-basal ganglia connectivity in a non-human primate model of Huntington's disease

Huntington's disease (HD) is a degenerative neurological disorder caused by an expanded CAG repeat sequence in the dominantly-inherited HTT gene on chromosome 4. When the CAG repeat stretch exceeds 40 repeats the encoded mutant huntingtin protein (mHTT) misfolds, resulting in a toxic gain of function that is neurodegenerative. HD symptoms are detrimental to the patient's quality of life, as they suffer from a progressive hyperkinetic movement disorder accompanied by deteriorating cognitive function and profound personality changes/mood disturbances. The emotional and physical burden on both the patient and the caregiver are tremendous, and patients often report their mood symptoms to be the most burdensome to both themselves and their caretakers. To address this need, the central goal of my project will be to characterize the impact of HD neuropathology on limbic-basal ganglia connectivity and behavioral phenotypes relevant to the mood/psychiatric symptoms. I will use behavioral assays to assess mood and affect in our HD animal model, and I will perform neuroimaging, histological, and molecular analyses, focusing on specific regions of interest in limbic (amygdala, anterior cingulate cortex, orbitofrontal cortex) and basal ganglia (caudate and putamen) regions. In sum, I will take a multifaceted approach using both in vivo (neuroimaging and behavioral assays in Aim 1 and 2) and ex vivo (histological and molecular in Aim 3) techniques. The strength of my studies lays in their ability to identify prospective neuroimaging changes that can be connected with a wide array of behavioral and neuropathological phenotypes of HD.

Public health relevance
Huntington's disease (HD) is a fatal neurodegenerative disorder caused by a CAG repeat mutation in the HTT gene that leads to severe motor, cognitive, and mood symptoms for which there are no existing therapeutics that can slow disease progression. Although a number of studies in HD patients have reported that alterations in the amygdala, anterior cingulate cortex (ACC), and orbitofrontal cortex (OFC) correlate with psychiatric phenotypes, there is a critical need to gain further understanding of the neuropathological mechanisms by which these changes impair mood and thought. The proposed research in this application will use state-of-the- art neuroscience technologies (magnetic resonance imaging, behavioral analyses, and histological techniques) in a novel non-human primate model of HD recently created in my postdoctoral laboratory to 1) study alterations in brain circuitry between the basal ganglia and the amygdala, ACC, and OFC and 2) correlate changes in connectivity to the progressive development of mood phenotypes and related neuropathology.